New Algorithms and Software for Mass Spectrometric Analysis of Intact Proteins and Complexes

Intact proteins and multi-protein complexes represent two of the most important levels of
organization in biology, yet these levels are also some of the most difficult to study. Native
mass spectrometry provides a means to observe proteins in complex with ligands, other
proteins, and nucleic acids. The proposed project will build new algorithms and software for
intact and native mass spectrometry. Specifically, the project will further develop Protein
Metrics Intact Mass charge-deconvolution software, incorporating multiple information channels
(isotope spacing, co-elution, and charge states) into the core algorithm, so that the algorithm
can handle complex, low signal-to-noise mass spectra over a wide range of masses and
abundances. The project will also build automation software for analyzing data as it is produced
by mass spectrometry instruments, naming and organizing files, and producing reports showing
results at several levels of detail. The project will enable a number of interesting applications,
including small-molecule screening, large-molecule drug comparability, pharmacokinetics, and
protein / protein and protein / nucleic acid binding.

Public health relevance
We propose to develop commercial software products for determination of the masses of intact proteins and protein complexes, and accurate quantitative comparison of these masses across samples. We will also develop automation software to analyze data as it comes off the mass spectrometry instrument computer, and reporting software that will produce both interactive and static reports at a variety of levels of detail. The proposed project has the potential for great impact on human health in areas such as drug and vaccine development and therapeutic protein characterization.